INTERACTIVE MEDIA FOR PROMOTING DIABETIC FOOT CARE

There are more than 8,000,000 diabetics in the United States and 500,000 new cases are diagnosed each year. Diabetics are at high risk for serious foot problems due to vascular and neurological deficiencies. Foot infections and foot injuries occur frequently, and lower extremity amputations occur in 1% of diabetics each year, with notably higher rates in older, male, and African American subgroups. The systemwide cost for amputations in diabetic patients exceeds $750 million each year, and foot problems overall account for some 20% of diabetic hospital admissions. Many foot pathologies could be prevented by regular examination and routine self care procedures, but both patients and health care providers frequently neglect foot care issues. A multidisciplinary team will develop an interactive multimedia program to motivate and instruct diabetic patients regarding the prevention, early detection, and early treatment of foot problems. The program will be designed for both Caucasian and African American target audiences. Patients will be given an online risk assessment and then channeled to personalized instructional sequences. Principles of social cognitive theory and self efficacy theory will be incorporated into the program. Diabetic patients, family members, and health care providers will evaluate the interactive program. PROPOSED COMMERCIAL APPLICATION: Potential markets for this patient education product include primary care, geriatric, endocrinology, and podiatry practices in sole practitioner and group settings. Other significant markets include staff model HMO's diabetes and podiatry clinics, patient education departments in community and academic medical centers, and professional schools of podiatry and medicine. Marketing and distribution through consumer channels to diabetic patients with computers in the home is also under consideration.